Integrative Genetics and Genomics Core

PROJECT SUMMARY INTEGRATIVE GENETICS & GENOMICS CORE (IGGC)
The Center for Systems Neurogenetics of Addiction (CSNA)’s Integrative Genetics and Genomics Core (IGGC)
integrates and disseminates data from a coordinated, synergistic set of biobehavioral studies of psychostimulant
addiction susceptibility. Central to this integration is the expansion of systems genetics tools and approaches to
examine genetic correlations among addiction-related behaviors, identify underlying genes and variants,
pathways and neurobiological mechanisms and extrapolate them to human conditions. The IGGC provides
innovative systems genetics approaches, serving all projects with advanced analyses developed by the core
leads and others. The objectives of the IGGC are: 1) To deliver rigorous, reproducible experimental design and
molecular phenotyping through an Experimental Design, Colony Management and Sample Tracking service and
a Molecular Analysis service. Our experimental design will be executed with the assistance of a robust LIMS
system that facilitates rapid data dissemination. Genotyping, gene expression and other molecular analysis will
be conducted using validated protocols and data will be integrated with phenotypic data. 2) To develop and
implement traceable statistical, statistical genetics and bioinformatics pipelines for the expanded molecular and
behavioral phenotyping studies through a Statistical Genetic Analysis service. Rigorous integrative statistical
analysis of data generated by the CSNA will be performed using a suite of specialized tools devised largely by
the IGGC team, including reference trait analysis and genetic correlations. 3) To manage, integrate and
disseminate data through widely accessible cross-species genetic and genomic resources through Cross
Species Integration and Data Dissemination services. We will achieve cross species integration at the variant
and molecular level using the GeneWeaver platform, which enables multi-species data integration through
advanced combinatorial algorithms. Data will be shared through a suite of complementary and widely accessed
resources for integrative analysis and interpretation. Each service includes processes for quality control, quality
assurance and effective resource utilization by all members of the CSNA. The Core structure—based on our
experience that one cannot separate data analysis from careful experimental design and project management—
will ensure faithful execution of an integrated experimental protocol across the CSNA’s projects. The IGGC will
interact closely with the Behavioral Phenotyping Core to conduct complex behavioral analysis directed at
predisposing and drug self-administration traits, and the Mouse Resources and Validation Core to receive
validation cohorts for behavioral testing. By meeting standards for research reproducibility, data quality and data
integrity, the IGGC will enable discovery of novel biomolecular mechanisms of addiction susceptibility and ensure
lasting utility of CSNA data and research outcomes. The IGGC will play an integral role in skills development,
deliver its innovative approaches to other researchers using systems genetics populations and resources in
addiction genetics and genomics, and continue to prepare training materials for the global research community.